Dexmedetomidine Sublingual Film for the Ambulatory Treatment of Hyperadrenergic Autonomic Crisis in Patients with Familial Dysautonomia

ABSTRACT
This proposal tests a novel approach to treating hyperadrenergic autonomic crises in patients with a rare ge-
netic disease – familial dysautonomia (FD). FD is caused by an autosomal recessive mutation in the ELP1
gene and manifests in developmental delay, musculoskeletal abnormalities, labile blood pressure, chronic lung
infections, difficulty swallowing, and optic nerve atrophy. There are no disease-modifying therapies for FD. Hy-
peradrenergic autonomic crises are the most frequent and severe symptoms of FD, occurring as often as once
per day, with a median occurrence of once per month, are triggered by either physical illness or emotional exci-
tation, and entail acute elevation in blood pressure and heart rate, accompanied by continuous vomiting and
retching. Autonomic crises can be deadly or lead to secondary complications (i.e., bronchoaspiration; infec-
tions). Current approaches towards autonomic crisis resolution at home involve non-pharmacologic treatments
to decrease the sympathetic surge followed by benzodiazepines and clonidine, which may produce sedation
and carry severe side effects, such as hypotension and respiratory depression. Effective and safe therapies
that could abort or prevent autonomic crises in the at-home setting are desperately needed.
This study will test a novel approach toward autonomic crisis resolution at home. At the core of this approach is
the administration of sublingual dexmedetomidine (IGALMI™; BioExcel Therapeutics, Inc). IV dexmedetomi-
dine is the standard of care for aborting refractory autonomic crises when delivered intravenously (IV) but can
only administered in the ICU. The innovation of this new presentation lies in its mode of drug delivery, a sublin-
gual fast-absorbing film that can circumvent a patient’s swallowing difficulties and vomiting episodes, allow for
easy administration of the medication at home, and prevent hospitalizations. This study hypothesizes that
IGALMI™ film is more effective than placebo and non-pharmacologic treatments in terminating autonomic cri-
ses at home. Concurrently with IGALMI™ treatment, FD patients will undergo non-pharmacological interven-
tion via telemedicine and help manage symptoms and vital signs monitoring. An exploratory aim of this study is
the development of a methodology for predicting autonomic crisis onset 24 hours before the event to prevent
the crisis through early intervention. This will be achieved by collecting continuous data on patients’ trend
changes in vital signs through wearable device and AI analytics. In Aim 1 of this clinical trial, fifteen FD patients
will be randomized 2:1 into active treatment (IGALMI™) and placebo groups to receive medication/placebo at
the onset of the autonomic crisis in addition to non-pharmacological assistance through video. In Aim 2, we will
evaluate if patients had fewer hospital stays than the previous year by using IGALMI™ at home for crisis man-
agement. In Aim 3 of this study, data collected through a wearable Biobeat® device will be analyzed to identify
early signs of AC for each patient.

Public health relevance
PROJECT NARRATIVE Hyperadrenergic autonomic crises are episodes of drastic and acute increases in blood pressure and heart rate, accompanied by unremitting vomiting, retching, and are the most frequent and severe manifestations of a rare genetic disease - familial dysautonomia (FD). Hyperadrenergic autonomic crises result from improper develop- ment and function of the autonomic nervous system and are treated primarily using non-pharmacologic measures and at-home medications that carry severe side effects and don’t prevent secondary complications. In this study, we will test a new approach to resolving the autonomic crises in patients with FD that combines an easily deliverable and effective medication, sublingual dexmedetomidine film, along with non-pharmacological assistance through telemedicine and a wearable device that continuously records vital signs, to provide data to be applied towards the development of effective, at-home strategies for autonomic crises resolution and preven- tion.